Dissecting functions of IL-23-dependent inflammatory Th17 cells

Project Summary
Although IL-17-producing T helper (Th17) cells are a major pathogenic contributor to autoimmune diseases,
functional diversity undermines their potential as a prospective target for treating autoimmunity. Th17 cells are
currently classified into homeostatic and inflammatory subpopulations. It was noted that inflammatory Th17 cells
can be beneficial (anti-infection) and pathogenic (pro-autoimmunity). The distinction between homeostatic and
inflammatory Th17 cells has been extensively studied. However, how to dissect the anti-infection and pro-
autoimmunity functions of inflammatory Th17 cells is largely unknown. There is a critical need for this knowledge
given serious infections and fatal outcomes observed in patients receiving general inhibitors of inflammatory
Th17 cells (e.g. antibodies against IL-23). Herein, autoimmune and anti-infection subsets of inflammatory Th17
cells are for the first time distinguished experimentally. The objective of this grant is to elucidate the metabolic
regulation discriminating autoimmune and anti-infection Th17 cells derived from murine models and human
patients. The central hypothesis is that autoimmune and anti-infection Th17 subsets adopt distinct serine
metabolic programming. The rationale is that determining the differences between autoimmune and anti-infection
Th17 subsets will offer opportunities for novel therapeutics with substantially improved selectivity than the current
regimens. The central hypothesis will be tested by pursuing three specific aims: 1) to determine the mechanism
for regulating serine metabolism in the autoimmune Th17 subset; 2) to determine the mechanism by which serine
regulates pathogenicity of the autoimmune Th17 subset; and 3) to determine the transcriptional and metabolic
programming of Th17 cells from patients with inflammatory bowel disease (IBD). Under the first aim, autoimmune
Th17 cells recovered from murine models will be used to measure intracellular serine and indicators of
autoimmune pathogenicity with modulation of serine metabolic enzymes. For the second aim, biochemical
approaches and murine models will be employed to evaluate the relationship between serine-induced
intracellular methylation and pathogenic potential of Th17 cells. In the third aim, RNA-seq analysis will be
performed to evaluate transcription profiles of Th17 cells from IBD patients. The research proposed in this
application is innovative, because it focuses on the immunometabolic regulation discriminating anti-infection
and autoimmune Th17 subsets, a heretofore-unexamined mechanism. The proposed research is significant
because it is expected to provide novel opportunities to develop autoimmune Th17-selective therapeutics for
autoimmune diseases. This would be extraordinarily important for patients that have been infected or exposed
to certain pathogens, such as tuberculosis, since existing Th17 inhibitors cannot be used due to the risks of
decreasing the patients’ control of the infection.

Public health relevance
Project Narrative The proposed research is relevant to public health because autoimmune diseases, increasing in prevalence, is the top cause of morbidity in women in the United States; and despite significant advances in care, therapeutics usually lead to severe adverse effects due to insufficient selectivity. The proposed research is relevant to the NIH’s mission of reducing illness and disability because we will understand the pathogenic features distinguishing autoreactive T cell subset from normal cells, and this discovery will lead to new therapeutics for autoimmune diseases with substantially improved selectivity and reduced side effects.